Neural Processing During Sequential Saccades

Project Summary/Abstract
Visually scanning the environment requires a series of rapid eye movements, known as saccades,
interspersed with brief fixations, highlighting the remarkable speed of the brain’s oculomotor system. This
raises fundamental questions about whether the brain plans each saccade sequentially or plans future
movements before completing the current one. If the latter is true, this suggests that the brain must compute
the amplitude and direction of the future movement while accounting for the first saccade before it is even
initiated. This proposed research investigates the neural processing of the superior colliculus (SC) and
frontal eye fields (FEF) – crucial nodes in the oculomotor circuit – during the generation of sequential
saccades. The FEF, associated with cognitive processes like memory, and the SC, responsible for producing
corollary discharge signals, communicate bidirectionally to compute saccade metrics. Using laminar
multicontact probes, I will simultaneously record neural activity from the FEF and SC as rhesus macaques
perform tasks designed in a 2x2 framework, involving single or two sequential saccades, in visually- or
memory-guided domains. Advanced computational analyses will quantify the timing, directionality, and
representation of neural communication between these regions, specifically testing the hypothesis that
communication between the FEF and SC is enhanced during periods of increased cognitive processing (Aim
1). Furthermore, suprathreshold stimulation of the SC after prolonged fixation evokes a site-specific saccade,
but stimulation immediately after a saccade does not produce this movement. The oculomotor system requires
~250 ms to reset after a saccade, aligning with typical intersaccadic intervals during visual scanning. I will
apply electrical stimulation to the SC and FEF to test this phenomenon in tasks requiring sequential saccades.
Specifically, this work will test the hypothesis that if sequential saccades are treated as a unified action, the
resetting of the saccadic system should start with the second saccade (Aim 2). This proposed research will
uncover the neural signatures associated with executing sequences of movements, providing fundamental
insights into the neural mechanisms of sensorimotor integration. These findings may also inform treatments for
conditions that disrupt eye movement control, such as neurodegenerative diseases and traumatic brain injury.

Public health relevance
Project Narrative Generating multiple, reliable and fast eye movements to stimuli in our environment is essential in orienting us in the visual world, yet the communication dynamics between brain regions involved in this processing are not fully understood. Through experimental and computational methods, this project aims to investigate the communication between regions of the brain, specifically the superior colliculus and frontal eye fields, which are crucial nodes in the neural circuit that mediate the production of rapid eye movements. This project will provide fruitful insight regarding canonical mechanisms for neural representation and communication within the brain and can be extended to other sensorimotor systems.